Validation of Web-based Multimedia Dietary Assessment Tools

DESCRIPTION: There is an increasing demand for low cost and accurate methods to measure dietary intake and physica activity in epidemiologic studies. This proposal requests funds to examine the precision of two new dietar assessment tool, the Computer-Assisted Self-Interview Diet History (CASI-DH), which is modeled after th strengths of the diet history, one of the strongest dietary assessment approaches and ana fully automate multimedia 24 hour recall: DIETDAY. The CASI-DH is a web-based, self-interview approach that is meal- audio-, and food picture-based;generates nutrient and food intake estimates;has an extensive componen to assess dietary supplement use and provides feedback to help people adopt more healthful dietary habits It differs in many significant ways from food frequency questionnaires in that it is fully quantitative, include thousands of foods, is meal-based, and does not truncate foods or frequencies of consumption. Th objective of the validation study proposed here is to test how accurately these new tools capture usual die by comparing self-reported nutrient and food intakes obtained through the CASI-DH and using the DIETDA to objective validation biomarkers in a sample of 150 African American and 150 Caucasian adults Specifically, we aim to examine the validity of both instruments for intakes of nutrients (total energy, protein and potassium), vegetables and fruits and supplement use by using doubly labeled water for total energy 24-hour urinary nitrogen for protein;urinary potassium for dietary potassium;and blood levels of nutrient (carotenoids and tocopherols) for fruits, vegetables, and nutritional supplement use. A number of secondar aims will also be pursued, including validation of two physical activity questionnaires and two differen accelerometry approaches to DLW. To study the reproducibility of the CASI-DH, DIETDAY and DLW, repea measures will be conducted on a subset of 100 persons 6 months apart. Due to its low cost, the languag independence of the system, and the reliance on images for accurate communication, the CASI-DH an DIETDAY present unique opportunities for epidemiologic research in various populations for assessment o complex dietary exposures. Successful validation of either the CASI-DH or the DIETDAY will represen important methodological advances in nutritional epidemiology.Theepidemiology. The study will als contribute to our confidence in these dietary and activity assessment instruments in multiracial populations.